A Standardized Patient Approach to Measuring and Reducing Negative Attitudes Toward People with HIV and Substance Use Disorder among Dental Care Providers to Improve Care Outcomes

PROJECT SUMMARY/ABSTRACT
This project will use a novel standardized patient (SP) approach to more objectively measure negative attitudes
toward people with HIV (PWH) and people with substance use disorder (SUD) in dental settings in Kazakhstan
(KZ). This information will be used to inform development of a sustainable care improvement intervention for
dental providers in KZ. KZ has one of the world's fastest growing HIV epidemics, primarily driven by substance
use. HIV-related oral conditions adversely impact PWH's health and adherence to antiretroviral therapy (ARn,
problems that are compounded for HIV-positive people who use drugs (PWUD). Oral health problems and unmet
dental needs are common among PWH, and PWUD also have a high prevalence of oral health problems (e.g.,
xerostomia-induced dental caries, candida, tooth loss). Although dentists are responsible for treating the many
oral consequences of HIV and substance use, they report minimal, if any, training and knowledge in HIV and
patient substance use. Yet, their professional role has evolved to include some primary care, such as chairside
medical screenings (e.g., screening for ART adherence and SUD). Negative attitudes toward PWH and people
with SUD are key barriers to dental care for PWH and PWUD in KZ, especially for those with co-occurring
conditions; yet research on care improvement interventions for dental providers has largely been absent. Study
aims are: 1) identify drivers and manifestations of negative attitudes toward PWH, PWUD, and individuals with
co-occurring conditions among dental providers using nominal group technique and a refined unannounced SPbased
visit method to obtain a baseline assessment of these negative attitudes in 16 KZ dental clinics; 2) develop
an intervention that will increase screening for ART adherence and SUD by dental providers; and 3) conduct a
pilot cluster-randomized control trial assessing intervention feasibility, acceptability, and preliminary impact on
dental providers' a) negative attitudes toward PWH, PWUD, and individuals with co-occurring conditions, and b)
screening for ART adherence and SUD. This proof-of-concept study will advance methodologies that more
objectively assess negative attitudes among providers, enabling us to examine differences in having one health
condition versus two and to explore whether co-occurring negative attitudes have additive, multiplicative, or some
other combined effect. Including SPs with HIV and/or SUD as co-evaluators in assessing negative attitudes and
as co-developers and co-implementers of the resulting intervention will advance the field of HIV and SUD
intervention development that can improve HIV continuum of care outcomes for populations with co-occurring
conditions. Findings will inform design of a future large-scale R01 trial to rigorously evaluate the effectiveness of
SP-driven interventions in dental settings.

Public health relevance
PROJECT NARRATIVE This project will use a novel standardized patient (SP) approach to inform development of a care improvement intervention and, in a pilot cluster randomized control trial, assess its feasibility, acceptability, and preliminary efficacy on reducing negative attitudes toward people with HIV (PWH) and people with substance use disorder (SUD) among dental providers to promote chairside screenings for antiretroviral therapy adherence and SUD. NIH has emphasized the need for research on interventions to reduce negative attitudes toward PWH and their impact on the prevention and treatment of HIV/AIDS, particularly in low-resourced settings. The proposed study has the highest public health significance: it uses an SP approach to more objectively measure negative attitudes toward PWH and people with SUD, resulting in the creation of a better validated measurement tool, the development of a sustainable care improvement intervention for dental providers, and a tele-mentoring model that can be applied in US dental schools and dental clinics that serve Americans with HIV and SUD.